Next-generation nanoflow LC column technology to enable high sensitivity proteomics of limited samples

PROJECT SUMMARY
Molecular analysis of limited biological and clinical samples is of high significance and growing interest, as
observed from the exponentially increasing number of publications, citations, and startup businesses. Scarce,
precious, and amount-limited clinical and biological samples, including small-volume liquid biopsies (i.e., blood,
CSF, and other physiological fluids), microneedle tissue biopsies, rare cell isolates (e.g., circulating tumor cells,
cells from liquid biopsies, or laser-capture microdissected tissue biopsies), neonatal specimens, model animal
samples, dried blood spots, minute amounts of cells used in cell-based therapies, and even single cells and
organelles often hold keys for solving long-standing puzzles in biomedical research. Currently, the most efficient
technologies to tackle such limited samples rely on transcriptomic and genomic profiling techniques.
Unfortunately, genomic and transcriptomic profiles are poor surrogates for predicting quantitative proteomic
profiles, and these techniques cannot deliver structural and quantitative information for the characterization of
proteoforms, post-translational modifications (PTMs), and protein interactions, which are essential for
discovering cellular and molecular level pathways of disease, mechanisms of cell signaling, cell
activation/differentiation states, as well as novel biomarkers and therapeutic targets. Therefore, the ability to
reliably characterize proteomes in such limited samples will help define strategies for enabling early diagnostics
and personalized treatments of deadly diseases (e.g., cancer, Alzheimer’s disease, infectious diseases,
cardiovascular diseases, and traumatic brain injury), ensure the efficiency of cell-based therapies, characterize
cell model systems, and answer pressing questions in fundamental biology that could not be resolved before.
However, deep and high-sensitivity proteomic profiling of limited samples using conventional mass spectrometry
(MS)-based proteomic techniques is still a major challenge because (1) there are no amplification techniques
available for proteins, proteoforms, and PTMs, and (2) the current state-of-the-art conventional nanoflow liquid
chromatography (nanoLC) technologies provide suboptimal sensitivity and separation performance for scarce
samples. Consequently, numerous critical biological and pathological phenomena can not be investigated by
research laboratories using amount-limited samples, and multiple deadly diseases can not be diagnosed early
and successfully treated. In this study, we propose a unique ultra-low flow (ULF) proteomic technology based
on porous layer open-tubular (PLOT) and monolithic nanoLC columns developed by our laboratory that has the
potential to disrupt a sector of the nanoLC products market to enable deep proteomic profiling of scarce biological
and clinical samples that would be critical for numerous academic, clinical diagnostics, and forensic research
laboratories, as well as for industrial researchers in biotechnological, pharmaceutical, and instrument
development companies. In this study, our main goal is to develop, build, and thoroughly evaluate a
commercialization-ready prototype ULF LC platform based on our unique monolithic and PLOT columns.

Public health relevance
PROJECT NARRATIVE Deep proteomic profiling of scarce biological and clinical samples is still a major challenge since no amplification techniques are available for proteins and proteoforms, and current state-of-the-art proteomic techniques based on conventional chromatography columns coupled with mass spectrometry provide suboptimal performance and sensitivity levels. In this study, based on our novel, currently unavailable on the market, chromatographic column technology, we plan to build a reliable, robust, thoroughly evaluated commercialization-ready prototype chromatography platform to enable ultrasensitive proteomic profiling and address the challenges of numerous clinical, academic, and industrial laboratories. If successful, we will commercialize the technology to satisfy current customer needs in high-sensitivity proteomic analysis and tackle numerous biological and pathological phenomena that currently could not be investigated in amount-limited samples.